Planning and Evaluation

The Kimmel Cancer Center carries out a number of program planning and evaluation activities, and incorporates the resulting recommendations when charting future directions. Major planning activities include: (1) the annual meeting of the External Scientific Advisory Committee (ESAC); (2) the b-monthly meetings of the Executive Committee, which includes the Senior Leaders as well as the Program Leaders; (3) the periodic meetings of the Clinical Science Advisory Committee and the Basic Science Advisory Committee; and (4) the annual retreat and periodic faculty meetings

Public health relevance
Program Planning and Evaluation provides the overall strategic planning, oversight and evaluation of the Cancer Center.